University of Kentucky Alzheimer's Disease Research Center

Project Summary/Abstract: Overall
The University of Kentucky Alzheimer’s Disease Research Center (UK-ADRC) is an experienced and
collaborative center that has facilitated pioneering research in AD and related dementias (ADRD) since its
inception in 1985. Our principal mission is to serve as the focal point for all AD-related activities at UK and this
region of the United States, by providing an environment and core resources that catalyze innovative research,
outreach, education, and clinical programs. Our signature resources include: 1) a cognitively normal group of
~500 subjects followed longitudinally, together with ~300 additional subjects who transitioned to MCI or
dementia, and all committed to brain autopsy upon death; 2) a strong autopsy program with clinical-
neuropathological correlations and short postmortem interval research material; 3) a maturing program
studying the early preclinical biological emergence of mixed pathologies and how they contribute to late life
dementia states, with an increasing focus on antemortem biomarker collection; 4) an integrated centralized
database and innovative biostatistical expertise to characterize clinical and biological transitions; 5) a
successful and close partnership with the African-American community and increased participation of
underrepresented individuals in our longitudinal cohort and ADRC-affiliated research studies and clinical trials;
and 6) a rich, interdisciplinary training environment that provides multi-faceted educational opportunities for
researchers, healthcare providers, and our community partners. The overarching theme of the UK-ADRC is:
Transitions from Normal to Late-Life Multi-Etiology Dementia. Our well-characterized, longitudinal cohort
and historically strong neuropathology program focused on normal aging, preclinical disease states and early
cognitive transitions have been central to our success in defining early pathogenic mechanisms underlying the
transitions from normal cognitive aging to impairment. In addition, these efforts have been a driving force in our
recognition of the heterogeneity and multiple pathologies that characterize late-life dementia. The UK-ADRC
will continue to leverage our strengths to enhance our impact and “Centerness” by our focus on this
overarching theme, and the pursuit of four overall specific aims.
Aim 1. Facilitate and enhance basic, translational and clinical research in AD and related dementias.
Aim 2. Provide the necessary resources and interactive environment to support and create new opportunities
for innovative research.
Aim 3. Maintain and grow educational opportunities and community partnerships to promote awareness,
increase participation in research, and provide an innovative and interdisciplinary training environment.
Aim 4. Contribute to the national efforts and collaborative activities with other centers, programs and groups to
advance AD/ADRD research, education, and care.

Public health relevance
NARRATIVE: OVERALL The University of Kentucky Alzheimer’s Disease Research Center (UK-ADRC) facilitates and supports basic/translational and clinical research efforts to identify the early manifestations of disease and the pathogenic mechanisms underlying the transitions from normal aging to the development of cognitive impairment, with a special focus on mixed pathology and co-morbidities that influence risk and outcomes in late-life multi-etiology dementia. We are also dedicated to training the next generation of researchers, and to growing our educational programs and community partnerships to promote awareness of AD and related disorders and the importance of research and research participation.